Cellular Senescence in mediating age related TMJ Degeneration

Abstract
Advancing age is the single greatest risk factor for many diseases including TMJ degenerative disorders. TMJ
degeneration significantly impair the quality of life by causing acute and chronic pain, thus making this disease
a global health issue and a financial burden of epidemic proportion. As the United States and the world
population ages over the next several decades, the incidence of the TMJ degenerative disorders are expected
to rise substantially. As there is no effective treatment for the TMJ degeneration in an aged individual, there is
an unmet clinical need for an effective approach to treat TMJ degenration associated with old age.
The current proposal seeks to address this unmet clinical challenge using a highly innovative approach
(senolytics) that has never been tested before for the treatment of TMJ degenration. Our overarching
hypothesis is that cellular senescence plays a central role in age-related TMJ degeneration and targeted
elimination of the senescent cells may prevent or reverse the TMJ degeneration. To test this hypotheses, we
will examine: (1) Does eliminating the senescent cells by senolytics can inhibit or delay the development of age
related degeneration of the osteochondral tissues of TMJ? Using a triple transgenic reporter mouse (Col1a1 X
Col2a1 X Col10a1), we will examine the effects and mechanism of senolytics on the homeostasis of the
osteochondral tissues of the TMJ. (2) Does transfer of senescent cells into the young mice make the
osteochondral tissue of TMJ more prone to degeneration? We will transplant the senescent or non-senescent
control cells into 12-week-old male and female triple transgenic reporter mice and then assess the the
degeneration after the animals are euthanized. A combination of mechanical, immunohistochemical, molecular
biology and imaging techniques coupled with novel genetic mice models will be used to study the proposed
specific aims.
The proposed project has the immense potential to reveal new regulatory pathways that controls homeostasis
of the osteochondral tissues of the TMJ in an aged individual and to open new insight on understanding the
disease mechanism and developing therapeutic interventions.

Public health relevance
Narrative Temporomandibular Joint (TMJ) degenerates with advancing age and there are no effective treatments to prevent or inhibit the degeneration for the tens of millions of people. Cellular senescence is characterized by stable and irreversible arrest of cell cycle and has been implicated as a major factor influencing TMJ degeneration. This application focuses on understanding the role senolytics plays in preventing or inhibiting the TMJ degeneration with advancing age.